360° Collaborative Hub for AI in TMD Research (360° Chat-TMD)

360° CHAT TMD ABSTRACT
The proposed 360° Collaborative Hub for AI in TMD Research (360° CHAT-TMD) Center will establish a
national, interdisciplinary, patient-centered initiative aimed at advancing temporomandibular disorder (TMD)
research and improving clinical care. By uniting experts from the University of Michigan, Harvard University,
and Mass General Brigham, alongside patient communities, the project seeks to bridge critical knowledge gaps
in TMD and chronic overlapping pain conditions (COPCs). The collaborative focuses on four key objectives:
creating an integrated computational and data science infrastructure, implementing standardized training
programs, conducting interdisciplinary research to uncover TMD mechanisms, and enhancing collaboration
through innovative technologies. The project is structured around two cores and two research projects. The
Bioinformatics and Data Science Core (BDSC) serves as the computational and analytical hub, establishing
TMD-specific common data elements (CDEs) and harmonized data integration pipelines. It leverages
advanced AI/ML techniques for multi-modal disease phenotyping, fosters collaboration through secure,
privacy-preserving data-sharing ecosystems, and provides biostatistical and data science expertise to study
TMD subtypes, progression, and treatment outcomes. The Outreach and Training Core (OTEC) focuses on
education and training, enhancing accessibility to TMD/COPCs resources for medically underserved
populations and developing career development programs to mentor the next generation of clinician-scientists.
Research Project 1 employs a multi-level approach to understand TMD mechanisms, using animal models to
study structural changes, pain, and dysfunction, while exploring therapeutic strategies targeting pathways like
hedgehog signaling and inflammation. Research Project 2 integrates AI/ML technologies for whole-person,
whole-healthcare, and whole-community research. It aims to classify TMD subtypes, predict progression, and
implement mobile clinical chatbots for remote outreach and patient classification. Together, these efforts align
with NIDCR’s IMPACT mission and aim to transform TMD research, improve clinical care, and ultimately
enhance the quality of life for patients suffering from TMD and related chronic pain conditions.

Public health relevance
360° CHAT-TMD NARRATIVE The 360° Collaborative Hub for AI in TMD Research (360° CHAT-TMD) aims to establish a national, interdisciplinary, and patient-centered research initiative to address the critical need for interdisciplinary, patient-centered approaches to advance understanding and treatment of temporomandibular disorders (TMD), which affect millions and are often linked to chronic overlapping pain conditions. By partnering with the University of Michigan, Harvard University, Mass General Brigham, and patient communities, the Hub will integrate basic and clinical sciences, offer advanced training, and translate discoveries into evidence-based treatments. Leveraging AI/ML technologies, the consortium will develop a robust data science infrastructure and conduct interdisciplinary research to improve diagnostic accuracy, treatment efficacy, and overall patient outcomes in TMD care.